The role of lipid reprogramming in ferroptotic cell death in inflammatory bowel disease (IBD)

ABSTRACT
Inflammatory bowel disease (IBD) is a chronic relapsing inflammatory condition of the gut that impacts over a
million people in the U.S. yearly. There are two major forms of IBD, Crohn’s disease (CD) and ulcerative colitis
(UC). Chronic inflammation and unregulated mucosal immune activation lead to epithelial damage in a self-
perpetuated cycle that is difficult to treat, and many patients require surgical resection of the inflamed foci. CD
and UC are histologically distinct, yet the enhanced production of reactive oxygen species (ROS) is a hallmark
for both CD and UC. The increase in ROS is thought to be a major mechanism of epithelial cell death in IBD.
Indeed, mouse models of colitis are highly protected from tissue injury following antioxidant treatment. However,
inhibiting ROS in IBD has only led to modest benefits in disease activity in patients. It is well appreciated that
ROS can induce cell death via both regulated and unregulated cell death pathways and better characterization
of these are needed in IBD. Mining of a large RNA-seq database of IBD, we identified an iron and lipid signature.
Iron-induced lipid peroxidation is a hallmark of a relatively recent described form of cell death termed ferroptosis.
The two most well studied effectors of ferroptosis are the System Xc- transporter and glutathione peroxidase
(GPX)4. System Xc- is a heteromeric amino acid antiporter which mediates the import of extracellular cystine
in exchange for intracellular glutamate. SLC7A11 is the subunit of the dimer with transport activity.
Intracellular cystine is converted to cysteine for production of the antioxidant glutathione. GPX4 utilizes
glutathione to reduce lipid peroxides. Ferroptosis can be synthetically activated via pharmacological or
genetic inhibition of SLC7A11 or GPX4. More recent work has shown that ferroptosis is highly integrated to
cellular lipid metabolism and the long-chain-fatty-acid-CoA ligase (ACSL)4 is a central executioner of
ferroptosis. Deletion of ACSL4 leads to resistance, whereas increased expression leads to susceptibility to
ferroptosis. I show that in acute models of intestinal injury, no ferroptosis is observed. Whereas, ferroptosis is a
major hallmark in IBD patient samples and mouse models of chronic intestinal injury. Interestingly, deletion of
GPX4 or SLC7A11 in intestinal epithelial cells did not increase ferroptosis basally or in acute models of colitis.
However, these mice were highly susceptible in chronic models of intestinal injury. Consistent with these data, I
have shown that ACSL4 is significantly upregulated in IBD, but not acute models of intestinal injury. Building on
the preliminary data, I hypothesize that cellular lipid reprogramming via ACSL4 in chronic inflammation initiates
ferroptosis in IBD. Aim 1 will assess if ferroptosis inhibitors are central protective mechanisms in models of IBD.
Aim 2 will test the translational value of ACSL4 modulation in preclinical models of IBD. The importance of ROS
in IBD emphasizes the need to understand how ROS can lead to cell death and injury. Upon completion of these
aims I will define novel mechanisms, therapeutic targets and downstream pathways which integrate cellular
nutrient reprogramming and cell death in IBD.

Public health relevance
Project Narrative Inflammatory bowel disease (IBD) is a major global health burden affecting millions of people worldwide. I will use genetically engineered mouse models (GEMMs) and integration of transcriptomic and lipidomic approaches to determine how cellular lipid reprogramming in chronic inflammation initiates ferroptosis, a novel iron-dependent cell death mechanism in IBD.